Role of chromatin mechanics in nuclear shape and integrity

Project Summary
Abnormal nuclear shape is a diagnostic marker of disease progression and contributes to cellular dysfunction.
Perturbations to major nuclear rigidity components, chromatin or lamins, results in a weaker nucleus that is
deformed by external and/or internal forces to produce nuclear blebs and ruptures causing cellular dysfunction.
Previously, we revealed that, independent of lamins, chromatin compaction via histone modification state (eu-
/heterochromatin) determines nuclear mechanics, shape, rupture, and function. Changes in heterochromatin
subtypes, transcription activity, and mitotic segregation are well-known to occur in diseases presenting abnormal
nuclear morphology. The overall goal of my research program is to identify how nuclear rigidity, shape, and
rupture are controlled to maintain proper genomic and cellular function. The central hypothesis is that chromatin
rigidity via heterochromatin subtypes, chromatin motion via transcription activity, and chromatin organization
during mitotic segregation drive the mechanisms underlying nuclear physical properties. This hypothesis
addresses three knowledge gaps. First, what are the specific components that provide heterochromatin rigidity?
Heterochromatin is composed of subtypes, constitutive vs. facultative, and their specific histone modifications
that facilitate chromatin compaction and may have distinct impacts on rigidity. Second, is there another
contributor to nuclear deformation? While actin compression and contraction provide an external nuclear
deformation, transcription-driven chromatin motion represents a potential new internal nuclear deformation.
Third, is there an alternative mechanism to cause abnormal nuclear shape? Mitotic segregation error represents
a potential new mechanism of abnormal nuclear shape and rupture through chromatin disorganization during
nuclear reformation. We are qualified to determine nuclear rigidity using our lab’s innovative micromanipulation
single nucleus force-extension technique that has the unique ability to separate chromatin and lamin rigidity
contributions. We will couple this with measuring nuclear shape/blebbing and rupture through tracking NLS-GFP
via live cell microscopy. Our preliminary data show that heterochromatin histone modifications have distinct
effects on nuclear shape while transcription inhibition suppresses nuclear blebbing and rupture independent of
nuclear rigidity. Our preliminary data also show that miotic segregation errors cause both abnormal nuclear
morphology and rupture. This work will provide a deeper understanding of the established interphase blebbing
pathway by determining heterochromatin subtypes’ distinct physical contributions and a new contributor in
transcription-driven deformation. This proposal will also identify a new mechanism for abnormal shape via mitotic
segregation error. Identifying the role of heterochromatin subtypes, transcription activity, and mitotic segregation
error to nuclear rigidity, shape, and rupture will enlighten the underlying causes of abnormal nuclear morphology
and provide therapeutic targets for restoring nuclear shape and function in human disease.

Public health relevance
Project Narrative This is relevant to public health because abnormal shape of the cell nucleus is a hallmark of human disease. A weaker nucleus leads to abnormal shape and eventual rupture resulting in disruptions of normal cell functions. We will determine how the changes to genome compaction, reading, and division cause abnormal shape of the cell nucleus, a dysfunction that contributes to human disease.